HPV ECHO: Increasing the adoption of evidence-based communication strategies for HPV vaccination in rural primary care practices

Abstract of the Parent Grant (5R37CA253279-03; William Calo, PI)
Despite the availability of the human papillomavirus (HPV) vaccine that can prevent over 34,800 HPV-related
cancers in the US every year, only 51% of girls and boys were up-to-date by 2018. Rural populations are the
most impacted by HPV-related cancers. Best practices like the Announcement Approach training and systems
communication have proven effective in increasing HPV vaccination, but rural providers struggle to access and
implement such best practices. These data prompt the question: “How can academic centers support HPV
vaccination in rural primary care practices?” Although never tested for HPV vaccination, the ECHO (Extension
for Community Healthcare Outcomes) Model is a promising implementation strategy (practice facilitation) that
allows “experts” at academic centers to connect with primary care providers to discuss best practices in care
and complex cases managed within local practices. The objective of this R01 is to test two ECHO-delivered
HPV vaccination communication interventions in rural primary care clinics. The first will provide Announcement
Approach training (HPV ECHO); the second will provide this approach plus systems strategies to communicate
with parents who initially decline vaccination (HPV ECHO+). The rationale for the project is that ECHO is a
robust, highly-accessible platform to deliver best practices to rural providers and address the context-specific
communication needs of parents. Our long-term goal is to improve HPV vaccination rates in rural clinics and
reduce the health inequity rural populations experience in cancer outcomes. Aim 1 is to evaluate the impact of
HPV ECHO and HPV ECHO+ on HPV vaccination among adolescents. We will conduct a 3-arm cluster
randomized trial with 36 primary care clinics in rural Pennsylvania. Clinics will be randomized to: HPV ECHO,
HPV ECHO+, or control. Our primary outcome will be change in HPV vaccine initiation (≥1 doses) among
adolescents, ages 11-14, at 12-month follow-up. Aim 2 is to evaluate the impact of HPV ECHO and HPV
ECHO+ on implementation outcomes. Guided by implementation science frameworks, we will conduct a
mixed-methods evaluation to compare interventions on acceptability, adoption, cost, penetration, and
sustainability. Aim 3 is to evaluate the impact of interventions’ vaccine information on secondary acceptance of
HPV vaccination at the clinic level. We will also follow a subset of 200 vaccine-declining parents for up to 12
months to assess exposure to and impact of vaccine information from study arms versus naturally-occurring
sources (e.g., social media) on secondary acceptance. Our expected outcome is to demonstrate the
effectiveness of a highly efficient and scalable implementation strategy, ECHO, to support HPV vaccination in
rural clinics. This study is innovative in leveraging existing infrastructure at academic centers to deliver best
practices for HPV vaccination where they are needed most and in developing a greater understanding of the
influences on decision making among vaccine-declining parents. We expect the project to have a significant
impact on HPV vaccine uptake as we address the communication needs of both rural providers and parents.

Public health relevance
Project Narrative This diversity supplement will promote the career development of Miss Josheili Llavona-Ortiz, a Hispanic doctoral student with the long-term goal of becoming an independent cancer researcher. The proposed supplemental work is a mixed-methods study to assess the impact of the COVID-19 pandemic and the approval of COVID-19 vaccines on both HPV vaccination rates in primary care clinics and the way providers recommend the HPV vaccine to parents of adolescents. The research and training activities of this supplement will allow Miss Llavona-Ortiz to achieve the following short-term career goals: 1) To expand her content expertise in HPV vaccine communication and cancer prevention; 2) To help her acquire practical experience in mixed methods; 3) To help her continue to develop scientific writing skills as applied to manuscript and grant preparation; and 4) To improve her presentation skills by participating in national scientific meetings and cancer control planning events.